Clinical Evaluation of an Alarm Activated Detection System to Enable Early Intervention of Emerging Respiratory Decline with the Linshom Medical Continuous Predictive Respiratory Sensor (CPRS)

Abstract:
This CRP proposal will fund clinical development activities focused on demonstrating the health economic
value of Linshom’s continuous predictive respiratory monitoring (CPRM) system. The CPRM system has the
potential to reduce morbidity and mortality due to respiratory compromise, while reducing health care system
costs. Current devices and systems (human and machine) for respiratory monitoring are responsive by
sounding a warning alarm when a patient reaches a threshold of a physiologic parameter (i.e. SpO2, ETCO2)
and the patient is currently or has been in distress. Technological limitations have prevented the field from
moving further in its ability to predict patient decline so that health care providers (HCPs) are able to intervene
and stop or correct respiratory decline. Linshom has developed a simple, inexpensive solution for continuous
monitoring of respiratory functions including RR, TV, MV, I:E ratio, and apnea detection. Linshom's 510(k),
FDA-cleared Continuous Predictive Respiratory Sensor (CPRS) solves existing unmet needs mentioned above
with a small, portable, and inexpensive sensor and monitor that tracks RR, TV, MV, seconds since last breath
(SSLB), and I:E ratio in real time. These parameters are crucial for monitoring of patients suffering from both
acute and chronic respiratory illness. Unlike other respiratory monitoring technologies, Linshom offers an
operating room-quality respiratory profile at the patient bedside, which allows health care providers to promptly
diagnose emerging respiratory decline and intervene with appropriate medical care. Timely intervention should
reduce morbidity and mortality and result in significantly improved care for the patient and large savings for the
health care system via reduction in rapid response activation and ICU transfers. Linshom’s unique ability to
provide TV (and thus MV) in the non-intubated patient creates a profile of patient respiratory status previously
not available outside of the OR or ICU (and only in intubated patients).
In this CRP proposal we will generate clinical data proving Linshom CPRM’s ability to reduce the frequency
and length of respiratory depression episodes (RDE) more effectively than SoC alone in post anesthesia care
units (PACU). We expect the results of this trial to demonstrate the effectiveness of the CPRM system in
providing measurable benefit to hospital systems by reducing the burden of respiratory distress in the PACU.

Public health relevance
Project Narrative The goals of the project will be to advance key commercially enabling milestones and demonstrate the health economic value of the Linshom CPRM system in a clinical setting. This research will demonstrate a superior method of respiratory monitoring that will be first to enable continuous predictive respiratory monitoring (CPRM) at the patient bedside and in the future at the patient’s home. Successful adoption of the Linshom system will move the entire field of respiratory monitoring from responsive (too late) to predictive, where patient respiratory decline is identified when health care providers can take action and pre-empt patient decline. This will reduce morbidity, mortality and healthcare expense.